ALIVE: Development and feasibility of a psychosocial intervention for sexual and gender minority autistic adults

PROJECT SUMMARY
This is a K23 award application for Dr. Laura Graham Holmes, a clinical psychologist with expertise in autism,
to independently conduct research to develop psychosocial interventions that will improve mental health and
quality of life for autistic adults. The K23 will provide her with the support necessary to acquire critical skills in
three key career development areas: 1) community-engaged intervention development; 2) clinical trial design
and evaluation of implementation; 3) developing ethical data and safety monitoring protocols for populations at
heightened risk for suicide. To achieve her goals, Dr. Graham Holmes has assembled an interdisciplinary
mentoring team comprised of Dr. Susan White (Co-Primary Mentor), a recognized leader in psychosocial
intervention development in autism, Dr. Sarit Golub (Co-Primary Mentor), a leading expert in clinical trials and
implementation research with sexual and gender minority populations, and Dr. Carla Mazefsky (Co-Mentor), a
pioneer in research on emotion dysregulation and suicide in autism. Complementing these experts, Dr. Graham
Holmes also has a 5 member advisory committee to support her proposed development of a psychosocial
intervention for sexual and gender minority autistic adults.
A substantial proportion of autistic people identify as sexual or gender minorities (e.g., lesbian, gay, bisexual,
transgender or gender non-conforming). Current evidence demonstrates that autistic sexual and gender minority
people are at increased risk for co-occurring mental health conditions including depression, anxiety, and suicide
attempts compared to autistic cisgender heterosexual adults and report more unmet mental health care needs.
Dr. Graham Holmes’ objective is to address the lack of available evidence-based psychosocial interventions for
this population. Her research will result in preliminary data to support a clinical trial to test a novel community-
based minority stress intervention for sexual and gender minority autistic people. The intervention will adapt
evidence-based principles for addressing minority stress among sexual and gender minorities using a co-
designed, co-facilitated, online group psychoeducation intervention approach. She proposes the following
Specific Aims: Aim 1: Gather formative qualitative data from autistic sexual and gender minority people and
professionals with relevant experience to inform the development of the Autistic LGBTQIA+ AffIrming
InterVEntion (ALIVE); Aim 2: Pilot test and refine the intervention content, delivery, and efficacy and
implementation measures via a randomized controlled trial in preparation for a Hybrid Type 1 (efficacy +
implementation) clinical trial.
The proposed research is significant because it will result in an accessible, scalable intervention for a
vulnerable, underserved population. The proposed research is innovative because it uses an evidence-based
approach designed to address minority stress that will be adapted via a community-engaged process for a
population with multiple intersecting minority identities.

Public health relevance
PROJECT NARRATIVE Autistic sexual and gender minority adults are at high risk for co-occurring mental health conditions including depression, anxiety, and suicide attempts and require a psychosocial intervention tailored for their unique needs. This research involves developing and piloting a novel community-based minority stress intervention for autistic sexual and gender minority individuals. The emphasis on preparing for future adaptive interventions and on safe, ethical research with a population at heightened risk for suicide will make significant contributions to the autism research field and will promote the ultimate goal of improved psychosocial functioning and mental health in the autistic community.